Animal Models

PROJECT SUMMARY: ANIMAL MODELS MODULE
The Vanderbilt Vision Research Center (VVRC) includes faculty investigators with strong interest in
discerning relationships between visual circuits and behavior, between cortical structures and physiology, and
between brain regions and perception/behavior in non-human primate and prosimian species. These
cognitive- and systems-level investigations require access to expert veterinary husbandry and surgical skills,
especially for longitudinal studies requiring use of the same animal cohort over many months. Many of these
investigators and those using smaller rodents have increasing need of veterinary support for noninvasive live
imaging through the Center for Small Animal Imaging (CSAI) within the Vanderbilt University Institute for
Imaging Science, while others require expert guidance on animal model development, protocols, and
specialized care during longitudinal experimentation. The purpose of the VVRC Animals Models Module, which
is housed in Wilson Hall near primary users and directed by NEI R01 funded Christos Constantinidis, is to
provide a comprehensive veterinary service for support of vision research using non-human primates and other
mammals that is not covered by staff members supported by individual grants. This module is a VVRC-intrinsic
core administered through the Department of Psychology and is provided to VVRC members by request and
not through the VUMC Office of Research scholarship platform. In the current funding cycle, 6 investigators
with current NEI R01 awards used the Animal Models service for experiments with non-human primate or pro-
simian species (Calkins, Constantinidis, Kaas, Maier, and Tong), as did an additional 4 investigators with NEI
pending NEI R01 proposals (Bastos, Rex, Wareham, Woodman). Other vision scientists with NIH funding
round out this particular user base (Hoffman, Ramachandran, Wallace, Womelsdorf, and Woodman. In the
current funding period, the Animal Models service contributed material for 101 publications involving 13 VVRC
faculty authors. Projected use of the service module is considerable, with 11 of 16 current NEI R01 grant
holders projecting moderate (6) to extensive (5) use of the core. Of our 7 members with NEI RO1 proposals in
review, 5 will have moderate to extensive use. Leveraging this success, the VVRC Animal Services Module
will: (1) provide expert assistance with nonhuman primate surgical procedures, (2) provide training on best,
aseptic, nonhuman primate surgical practices, (3) support breeding of prosimian species used for vision
research, (4) facilitate access to and use of a multi-modal set of imaging tools for the study of vision in animal
models, and (5) provide veterinary guidance and expertise for model and protocol development. These
services and resources will enhance the scope of experimentation NEI-funded VVRC investigators conduct,
promote innovation through specialized veterinary procedures to those who otherwise would not have such
capabilities, including early-career vision scientists competing for extramural funding for their laboratories and
established investigators who rely upon the use of non-human primates for their research.